Cytoplasmic remodeling during the vertebrate oocyte-to-embryo transition

Project Summary/Abstract
Reproduction is crucial for the survival of all species. Reproductive success can be influenced by genetic and
environmental factors. In humans, at least 30% of infertile couples are diagnosed with unexplained infertility,
arguing for the existence of novel mechanisms that are critically important for reproduction. The oocyte-to-
embryo transition (OET) is crucial for reproduction. Prior to the OET, the oocyte accumulates large amounts of
maternal products during oogenesis and is maintained in the ovary in a quiescent state. During the OET, the
cellular organelles and maternal gene products stored in fully-grown oocytes are precisely remodeled to
orchestrate the OET. Currently, the mechanisms responsible for these cytoplasmic remodeling events during
the OET remain largely unclear. In an effort to study the cytoplasmic remodeling during Xenopus OET, we
uncovered a novel function of the ER in controlling the localization of maternal mRNAs. We found that maternal
RNAs are abundantly associated with the ER in the oocyte. After oocyte maturation, ER-associated mRNAs
are released into the cytosol. The remodeling of the ER and decreased mRNA-ER association during oocyte
maturation offer an important mechanism to sort maternal RNAs and correct localization errors that may have
occurred during early oogenesis. It also contributes to the overall increase in protein synthesis rate after oocyte
maturation. Furthermore, our preliminary results demonstrate that a subset of maternal mRNA undergoes
phase transition during the OET. Based on these exciting findings, here we propose to test the hypothesis that
dynamically regulated ER remodeling, mRNA-ER association, and RNA phase transition represent novel
cytoplasmic remodeling mechanisms that are fundamentally important for vertebrate OET. To test this
hypothesis, we propose 1) To determine the extent to which the remodeling of the ER, regulated mRNA-ER
association, and RNA phase transition during the OET are evolutionarily conserved, 2) To investigate the role
of the Cdc42-Wasl-Arp2/3 signaling cascade in regulating ER remodeling during the OET, and 3) To determine
the extent to which exposure to an environmentally relevant phthalate mixture impairs cytoplasmic remodeling
during the OET. The proposed work is expected to identify novel mechanisms that act during the OET to
influence vertebrate reproductive success. This could have a major impact on improving human reproductive
health.

Public health relevance
Project Narrative In humans, at least 30% of infertile couples are diagnosed with unexplained infertility, arguing for the existence of novel mechanisms that are critically important for reproduction. Remodeling of the cytoplasm during the oocyte-to-embryo transition is critically important for reproductive success, but how cytoplasmic remodeling is regulated remains poorly understood. By investigating how genetic and environmental factors regulate cytoplasmic remodeling during the oocyte-to-embryo transition, this project will have a major impact on improving human reproductive health.